A mechanistic investigation of risk factors for opioid use disorder: Examining hippocampal-based context-dependent learning and memory associated with adverse childhood experiences

Abstract
Opioid medications have been widely prescribed in efforts to control medical and surgical pain, but opioid use
disorder (OUD) has become a serious, prevalent, and costly public health problem. Identifying risk factors for
the development of OUD after prescribed opioid use could help reduce serious injury and mortality-related
outcomes, like overdose. Hippocampal (Hpc)-circuit based context processing is an important neuro-cognitive
process associated with OUD. Evidence for context processing deficits is seen in psychiatric, substance use,
and chronic pain populations. One major predictor of adult OUD that is also linked to context processing is
adverse childhood experiences (ACEs). ACEs predict high OUD rates and are associated with complex co-
morbidity (e.g., chronic pain, psychiatric conditions, other substance use disorders) that complicates treatment
for OUD. ACEs also compromise Hpc function through detrimental effects of stress hormones on Hpc neurons.
Thus, ACEs may lead to Hpc circuitry dysfunction and context processing deficits, providing a shared pathway
to chronic pain, prescribed opioid use, and OUD development. This Katz R01 will utilize the PI’s expertise in
neurocognitive mechanisms of trauma to provide the first direct examination of a mechanistic pathway of risk
for OUD that involves links between ACEs and context processing deficits. We will examine 75 adults with
OUD taking the prescription opioid agonist buprenorphine (BUP) and compare them to two control groups: 75
adults without OUD taking BUP and 75 adults without OUD and not taking BUP, in a cross-sectional study. We
will use a well-validated context processing paradigm to interrogate Hpc structure and function and behavioral
performance. Validated self-report and objective measures of opioid misuse, OUD, and ACEs will be used to
examine links between ACEs, context processing, and OUD. Our specific aims include: 1) identifying Hpc-
circuit based context processing deficits in OUD, independent of opioid agonist effects; 2) establishing
links between ACEs, context processing, and OUD severity; and 3) exploring how common symptom
domains are associated with ACEs, context processing, and OUD. The findings from this project will lead
to longitudinal work with the potential to trace a mechanistic pathway that helps explain co-morbidities between
chronic pain, stress-related disorders, and OUD development after prescribed opioid use. This may ultimately
open new doors to discovery of prevention and treatment paradigms that will identify those at risk when opioids
are prescribed (high ACEs, poor context processing), and ultimately shape neuroscience-informed ways to
remediate functional deficits even after they have developed.

Public health relevance
Narrative The US is dealing with an opioid crisis; up to 11 million people are misusing their prescription opioids, leading to high rates of overdose and death. While adverse childhood experiences are a risk factor for opioid misuse and opioid use disorder, the neurocognitive pathways underlying this link are not known. This project will test the hypothesis that hippocampal-associated context-dependent learning and memory is a crucial link between adverse childhood experiences and opioid use disorder, with findings informing efforts to create individually tailored prevention and treatment to reduce opioid misuse and overdose.